Randomized controlled trial evaluating an innovative community-based intervention combining group-based exercise and behavioral health skills-training for older adults with painful knee osteoarthritis

PROJECT SUMMARY
Knee osteoarthritis (OA) is a highly prevalent, leading cause of pain that limits physical functioning in older
adults. Although clinical practice guidelines recommend physical exercise for managing symptoms of knee OA,
several systematic reviews indicate that exercise intervention studies provide only short-term benefits (lasting
<6 months) for knee OA. Many older adults with painful knee OA return to sedentary lifestyles when structured
exercise programs end. Indeed, studies show that physical activity levels are low in this large, rapidly growing
population. Activity restriction (e.g., “resting”) is a key challenge to address as it is a common strategy older
adults use to reduce or prevent pain. Further, pain in older adults is strongly associated with fear of falling and
other comorbid symptoms, such as depressed mood, fatigue, and difficulty sleeping, all of which further limit
activity. Thus, efforts to increase and sustain physical activity in the geriatric knee OA population will require
restructuring maladaptive beliefs about exercise and pain, as well as promoting self-regulatory skills to develop
confidence to maintain an active lifestyle and manage symptoms that often limit activity. Therefore, we
developed a group-based behavioral health (BH) program for older adults with painful knee OA that
complements Enhance Fitness (EF) – a multicomponent, community-based exercise program for older adults,
involving balance, strength, and endurance training. The BH program (1) teaches coping skills to address pain
and related symptoms, emphasizing self-management and self-efficacy; (2) addresses fear of falling by
restructuring misconceptions to promote a view that falls risk is controllable; and (3) promotes walking behavior
by (a) using Fitbits for objective self-monitoring and goal-setting, (b) helping discouraged participants reframe
attributions of failure from uncontrollable to controllable causes, and (c) using group-based problem-solving of
barriers to physical activity. Combining exercise with BH skills training can have reinforcing effects by
improving functional capacity, reducing pain, and increasing self-efficacy for managing arthritis symptoms and
achieving personal activity goals. Accordingly, our objective is to conduct a single-blind, randomized controlled
trial in 280 community-dwelling adults age ≥65 years with painful knee OA to determine the efficacy of a 4-
month intervention of EF+BH versus an active control group of EF and health education (EF+HE). We
hypothesize the EF+BH intervention will produce greater improvements in accelerometer-measured minutes of
moderate-to-vigorous physical activity (primary outcome) than compared with the EF+HE control group at 6-
month follow-up. Secondary outcomes include knee pain severity, knee pain-related functional limitations,
mobility function, and fatigue. We will also examine the mediational role of short-term changes (over 4 months)
in measures of self-efficacy and pain coping with physical activity outcomes at 6-month follow-up. If successful,
the EF+BH intervention has high potential for dissemination as a community-based, non-pharmacologic pain
management program for older adults with knee OA.

Public health relevance
PROJECT NARRATIVE Knee osteoarthritis is a common, leading cause of pain-related disability in older adults. We propose to evaluate a community-based intervention that combines physical exercise and behavioral health skills training to improve physical activity in older adults. Given the high burden of pain in the older adult population and limited treatment options that are safe and effective, our long-term goal is to establish a low-cost, effective behavioral health program for older adults with chronic musculoskeletal pain that complements existing community-based exercise programs and that can be widely disseminated.